Systematic Evaluation of the Application of Zebrafish in Toxicology (SEAZIT) Phase 2

The goal of this project is to generate information on the current state of zebrafish testing and to conduct experiments to determine if NTP can optimize a zebrafish testing protocol. A multisite study to evaluate the consistency of response will be performed. Keywords: zebrafish, toxicity, alternative model